ANTI-TNF CHIMERIC MOAB IN TREATING PTS W/ENTEROCUTANEOUS FISTULAE IN CROHN'S DIS

To evaluate the safety and efficacy of chimeric monoclonal anti-TNF antibody (cA2) compared with placebo closure of enterocutaneous fistulae in patients with Chron's disease.